Determinants of follicular helper T cell expansion in lupus

PROJECT SUMMARY/ABSTRACT
Systemic lupus erythematosus (SLE) is a complex autoinflammatory disease in which derailed follicular T helper
(Tfh) cells promote autoreactive B cells producing antinuclear autoantibodies implicated in the pathogenesis of
SLE. Thus, efforts to primarily program the metabolism of Tfh cells are of considerable interest to limit
autoantibody and alleviate the progression of lupus. We demonstrate that oral treatment with 2-deoxy-D-glucose
(2DG) integrates transcriptomic and metabolic signaling to synergistically limit glycolysis, resulting in peripherally
control of Tfh cells and significantly ameliorating lupus in mice. Furthermore, TEPP-46, which stabilizes
tetrameric pyruvate kinase muscle isozyme 2 (PKM2) and prevents its nuclear translocation, also programs the
transcriptomes of ileal epithelial cells (iECs) and Peyer’s patch (PP) B cells and reduces autoantibodies in lupus
mice. The objective of this research proposal is to further clarify the pharmacological effect of TEPP-46 compared
to 2DG, which restricts the metabolic circuits of intestinal cell complexes, particularly iECs that continuously
interact with the gut microbiome and physiologically support PP microenvironment. This contributes to restrictive
glycolysis in PP Tfh cells and critically limits the local B cell repertoire (e.g., IgA+ B cells) that support the microbial
taxa and regulate peripheral autoantibody, thereby synergistically ameliorating lupus in mice. Our hypothesis is
that TEPP-46-limiting glycolytic metabolism, like 2DG, physiologically rewires iECs to locally support the
programming of PP Tfh cells that regulate B cells to tightly control the gut microbiome and peripheral autoreactive
B cells, thereby mitigating the disease in the host. The specific aims are: 1. Elucidate the effects of TEPP-46
compared to 2DG on iECs and the gut microbiome in lupus mice. 2. Delineate the glycolytic regulation in locally
programming Tfh cells of lupus mice orally treated with TEPP-46 compared to 2DG. And 3. Investigate the
pharmacological control of local and peripheral B cells synergistically ameliorating lupus in mice. The expected
results will be the first detailed report of a compound-dependent therapeutic intervention programming key
glycolytic pathways (e.g., PKM2) that physiologically control the ileal epithelium and host microbiome to support
autoantibody-limiting Tfh cells, thereby effectively ameliorating the disease in mice.

Public health relevance
Project narrative The number of follicular helper T cells (Tfh) correlates with disease severity in lupus patients, and inhibiting glycolysis reduces the number of Tfh cells and eliminates disease in mouse models. We propose to expand these findings by evaluating how two glycolytic inhibitors, including one in clinical trial for another condition, can functionally reprogram Tfh cells and B cells in lupus to alleviate disease, with a focus on the gut mucosa, the entry point for these oral drugs. Using state-of-the-art multiomic approaches, these preclinical studies may highlight the therapeutic potential of these orally administrated compounds for the treatment of lupus in humans.